Columbia VA Summer Research Program

PROJECT SUMMARY
South Carolina (SC) is among the nation’s leaders in cardiovascular disease, kidney disease, diabetes, obesity,
hypertension, cancer, and mental health disorders, all of which disproportionately impact Veteran populations
and underrepresented minorities. The biomedical workforce in SC, and particularly the VA, is insufficient to
meet the challenges of the state. The purpose of this proposal is to continue the success of our pilot summer
program by giving high school students exposure to, and undergraduate students experience with, biomedical
research. The pilot CVAHCS Summer Research Program over the last two years demonstrated significant
achievements including 1) Support for 11 undergraduate students who conducted full time biomedical research
throughout the 8 week program. 2) Development and implementation of a high school research curriculum that
engaged >40 local students. 3) Administrative success to onboard all undergraduate students by the start of
the summer program and to ensure that all students received pay. 4) Organization, in coordination with
CVAHCS Center for Development & Civic Engagement (CDCE)/Voluntary Service, of an end of summer
“graduation” to celebrate the success of all students in the summer program. 5) A highly diverse group of program
participants reflecting the diverse applicant pool, a high percentage of which have biomedical related career
goals. This competitive renewal proposal adds new activities and innovations that were not implemented during
the first two years of the program. These include 1) Laboratory skills training for undergraduate students to
give all students basic laboratory competencies. 2) Additional near-peer mentoring opportunities to further
enhance the interaction between undergraduate and high school program participants. 3) Off campus
biomedical research and research career experiences for high school students. 3) Summer symposium for
undergraduate students to present their work to the high school students. The overarching goal of this program
is to enhance and refine the successful CVAHCS Summer Research Program to further build a diverse pipeline
of biomedical researchers that will ultimately address the health care challenges facing Veterans. The CVAHCS
in Columbia, SC is dedicated to promoting diversity, equity, and inclusion in both the biomedical research and
health care settings. We will achieve this goal through the successful implementation of two major objectives.
(1) To continue the successful CVAHCS Summer High School Research experience for students from diverse
backgrounds. (2). To continue the successful CVAHCS Summer Undergraduate Research program for college
students from diverse backgrounds. The CVAHCS is ideally positioned to continue this program over the next
5 years with committed staff and strong program leadership.

Public health relevance
PROJECT NARRATIVE The Columbia VA Health Care System (CVAHCS) was one of the original pilot sites for the VA Summer Research Program. The program was the only one in the United States to support both high school and undergraduate students. An innovative program and curriculum was developed for students to learn about and engage in biomedical related research in the VA. A highly diverse group of students was supported, and the administration of the program was highly successful. This proposal seeks to continue the success of the program over the next five years. The CVAHCS is committed to continual program improvement that will better serve the next generation of biomedical professionals in the VA.